Reduced EtO emissions to safeguard biomedical supply chains

Summary/Abstract
The overarching goal of this project is to protect the nation’s supply chain of critical medical
devices that are sterilized using ethylene oxide (EtO). Despite the search for alternative
approaches, a large fraction of single-use devices is sterilized with EtO. These devices, including
catheters, heart valves, and tracheostomy tubes, are critical to routine and life-saving procedures
and therapies. As regulations for EtO emissions become more stringent to protect workers and
communities from harmful exposure, there is a significant risk that supply chains for critical
devices will be disrupted, in turn threatening the health and well-being of the nation. The specific
objectives of this project include the development of a novel photocatalytic system to mitigate EtO
at levels that are hazardous but difficult to address with existing adsorptive and thermal catalytic
approaches. Specifically, the technology addresses concentrations in the range of 5 ppm and
below in sterilization facilities, transportation, and warehouses. These “fugitive emissions” are a
significant contributor to overall emissions and directly impact workers and community safety.
Objectives include determining operating conditions at which low concentrations of EtO (<5 ppm)
are oxidized at 99% destruction and removal efficiency (DRE) by identifying the optimum
photocatalyst and parameter space for achieving high DRE. The specific aims are: Aim 1)
optimize a 100 CFM photoreactor fluid flow, optical power, and catalyst parameters for 99% EtO
DRE at fugitive EtO concentrations, Aim 2) develop a 100 CFM system based on the photoreactor
from Aim 1 that can address EtO emissions in a real-world environment, Aim 3) evaluate
performance of the Aim 2 100 CFM system in a sterilization facility, and Aim 4) analyze the Aim
2 system operational lifetime factors. Various computational fluid dynamics and non-sequential
optical models will be leveraged by the experimental efforts. Standard and cutting-edge detection
approaches that are capable of measuring EtO into the low ppb and ppt ranges will be used in the
experimental program.

Public health relevance
Narrative Supply chains for more than 50% of medical devices are threatened by current and new ethylene oxide (EtO) regulations because of the limitations of current EtO control technologies. The proposed research will demonstrate an EtO abatement technology to minimize fugitive EtO emissions from sterilization facilities and warehouses beyond what is achievable with current approaches. The proposed technology addresses a void in current abatement strategies, creating the opportunity to dramatically reduce fugitive EtO emissions, ensure an uninterrupted supply chain of medical devices, and protect workers and communities from harmful EtO exposure.